Exploring hidden determinants of splicing with genome-targeted proximity labeling

PROJECT SUMMARY/ABSTRACT
The vast majority of human genes are multi-exonic and undergo alternative splicing to generate a several-
fold increase in the variety of transcripts and proteins that are produced. In diseases like cancer, splicing is often
globally aberrant and highly distinct from normal tissues, with increased levels of intron retention, alternative
splicing and usage of de novo splicing junctions. A fundamental unanswered question in RNA biology is how the
many layers that comprise the splicing code are interpreted to produce a given splicing outcome, and how these
processes become dysregulated in human diseases. The extensive crosstalk between processes occurring on
the DNA and those that act on the RNA suggest the chromatin state in particular may participate in orchestrating
alternative splicing. We have observed that random genomic integration of a splicing reporter construct results
in populations of cells corresponding to each possible splicing outcome, suggesting the genomic context at the
site of integration exerts a powerful influence on splicing. However, due primarily to technological limitations,
much remains unknown about the precise nature of the regulatory interplay between chromatin and RNA splicing
and the potential factors that may be involved. The goal of this proposal is to address the current challenges
impeding de novo discovery and develop unbiased experimental approaches to reveal hidden determinants of
splicing regulation at the chromatin level. Our approach is designed to directly connect splicing outcome with
unbiased proteomic profiling of the associated genomic region, in order to identify all of the potential chromatin
features that are involved in enforcing a particular pattern of splicing. We also propose to engineer new systems
to functionally validate a direct role for the epigenome in splicing regulation and to modulate splicing at will. Our
findings have implications for both epigenetics and RNA biology, and in particular, how their interactions
influence the various processes involved in gene expression. It also has the potential to shed insight into the
causes and consequences of the widespread epigenetic and splicing dysregulation observed in human cancer.
Importantly, our approach is not limited to the study of splicing and will also enable unbiased discovery of the
mechanisms involved in other fundamental processes.

Public health relevance
PROJECT NARRATIVE RNA splicing is an essential and typically accurate process that is responsible for generating mature messenger transcripts. However, many human diseases such as cancer are associated with disruptions to global splicing homeostasis and the underlying causes remain largely unknown. This proposal aims to examine the connection between epigenetics and splicing to uncover their relationship in both healthy and unhealthy contexts and identify new opportunities for therapeutic intervention.